Testing the Impact of Family-based Intervention to Improve Developmental and Health Outcomes for Female Adolescents.

PROJECT ABSTRACT
The proposed study seeks to address the urgent need for theoretically and empirically informed interventions
that would address the increasing numbers of unaccompanied minors migrating from rural to urban centers in
developing countries for better economic opportunities. This process often results in hazardous child labor
defined as work that is mentally, physically, socially or morally dangerous and harmful; interfering with schooling
and health and mental health functioning, and leading to several other disproportionate risks. Unaccompanied
migrant child laborers’ vulnerability is further intensified by the lack of parental protection and community
belonging in the host urban center. The International Labor Organization (ILO) estimates that 9.6% of children
(ages 5 to 17) across the globe are child laborers and draws attention to migrant child laborers as an
underreported and highly vulnerable group, a significant portion of which are female with no education. Poverty
has been identified as the main driver of child labor, with family context also being a critical contributing factor.
Sub-Saharan Africa (SSA) has the highest rates of child labor (24%), with Ghana -the focus of this study-
registering one of the highest child labor prevalence at 22%, including unaccompanied child migrant laborers. In
Ghana, unaccompanied adolescent girls migrate from the Northern region to urban centers in the south to work
in the informal economy. Load carrying is the most common type of labor for this population and exposes migrant
girls to multiple developmental and health risks. Building on the recently concluded R21 study (with 97 adolescent
girls aged 11 to 14 years and their caregivers) that showed high feasibility and acceptability, and promising
preliminary impact of the ANZANSI (resilience in Dagbani –local language) combination intervention in the same
region, we propose to test its effectiveness in a larger two-arm cluster randomized clinical trial among 960
adolescent girls (age 11 to 14 years) at risk of school dropout nested within 32 public junior high schools in the
Northern region of Ghana and their caregivers. The schools will be randomly assigned to one of two study
conditions: 1) ANZANSI (FEE+MFG) and 2) bolstered usual care. The intervention will be delivered for 12
months, with assessments conducted at baseline and at 12-, 24-, and 36-month follow-ups post-intervention
initiation. The study specific aims are: Aim 1: Examine the short- and medium-term impacts of ANZANSI
intervention on the incidence of unaccompanied migration for child labor (primary outcome), and academic
progress and psychosocial outcomes (secondary); Aim 2: Examine the impact of the ANZANSI intervention on
potential mechanisms of change at the individual, family, and community levels; Aim 3: Evaluate the cost and
cost-effectiveness of each intervention condition; and Aim 4: Qualitatively examine participants, facilitators, and
school leadership’s experiences with the intervention. Our results will inform approaches to prevent poverty-
impacted African female youth’s unaccompanied rural-to-urban migration to engage in child labor.

Public health relevance
PROJECT NARRATIVE While sub-Saharan Africa has the highest prevalence of child labor, including unaccompanied migration of adolescent girls for labor, theoretically and empirically informed interventions to prevent adolescent girls’ unaccompanied rural-to-urban migration for child labor are very limited. The primary aim of the proposed study is to test the impact and cost-effectiveness of an innovative combination intervention to curtail poverty-impacted African female youth’s rural-to-urban migratory patterns and involvement in child labor, and consequently reduce their exposure to work-related risk factors undermining their health, well-being and ultimately future. As several developing countries, including those in sub-Saharan Africa, continue to grapple with child labor, the study findings may inform multi-level response efforts desperately needed to prevent adolescent girls’ migration for child labor.